Role of Gs-alpha in pancreatic islet cell growth and function

We generated mice with Gs-alpha deficiency in beta cells (betaGsKO mice) by repeated matings of rat insulin II promoter-cre recombinase transgenic mice with floxed Gs-alpha mice which have loxP recombination sites surrounding Gs-alpha exon 1. BetaGsKO mice have very poor survival during the first several weeks of life in most cases associated with hyperglycemia and in addition had very poor postnatal growth. Studies in adult mice showed that betaGsKO mice had severe hyperglycemia and glucose intolerance despite having greater than normal insulin sensitivity. Impaired glucose tolerance was due to the fact that these mice were hypoinsulinemic, with reduced islet insulin content and glucose-stimulated insulin release. Although islet architecture was maintained, betaGsKO mice had significantly reduced beta cell mass with reduced beta cell proliferation and increased beta cell apoptosis. Studies on younger mice show that beta cell proliferation is reduced from birth. Although studies have suggested that Gs-cAMP mediates these effects on beta cell growth, survival, and insulin release by stimulating insulin receptor substrate 2 (Irs2) expression, we observed no change in expression of Irs2 or Pdx1, a beta cell growth gene which is induced by Irs2 signaling. Rather, there was a specific reduction in cyclin D2 expression. More recently we have made a second mouse line with beta-cell Gs-alpha deficiency using Pdx1-cre. These mice have Gs-deficiency throughout the endocrine and exocrine pancreas. Results show these mice to also develop severe insulin-deficient diabetes. However these mice have more or less normal survival and there is a greater proportion of pancreatic alpha-cells in the islets with no evidence for reduced proliferation of these cells. Moreover studies in an alpha-cell line showed evidence that Gs-alpha leads to reduced proliferation of these cells, indicating that Gs-alpha may have opposite effects on proliferation of alpha- and beta-cells, respectively. The exocrine pancreas was abnormal with enlarged ducts with large eosinophic cells, which may lead to GI malabsorption. We have most recently generated mice with Gs-alpha deficiency limited to alpha cells using a glucagon-cre transgenic mouse to examine the effects on alpha cells directly. Initial results in these mice show no obvious effects on body weight but there is an increase in islet size and mass, with a normal cellular architecture and relative abundance of alpha and beta cells. Studies are underway to understand this phenomenom, including cellular linear tracing and total and single cell RNAseq experiments. We are also examining the effects of activating Gs mutations in alpha and beta cells in vivo, respectively.